Qualitative and Patient-Reported Outcomes Shared Resource

QUALITATIVE AND PATIENT-REPORTED OUTCOMES SHARED RESOURCE (Q-PROSR):
PROJECT SUMMARY
The Wake Forest Baptist Comprehensive Cancer Center (WFBCCC)’s Qualitative and Patient-Reported
Outcomes Shared Resource (Q-PROSR) provides investigators with state-of-the-art methods for conducting
qualitative research and provides expert guidance on patient-reported outcomes (PRO) measurement. Its Co-
Directors are Erin Sutfin, PhD, and Lynne Wagner, PhD, both Professors in the Department of Social Sciences
and Health Policy and members of the WFBCCC Cancer Prevention and Control Program. Q-PROSR was
established in 2016 as a developing shared resource and adds new infrastructure to the institution to support
population and clinical researchthrough the following three Specific Aims: (1) provide operational and analytical
support to all areas of qualitative inquiry, including methodological design, selection and recruitment of study
samples, data collection, management of textual data, and qualitative data analysis; (2) support investigator-
initiated research and WFBCCC priority initiatives through consultation on patient-reported outcomes
measurement, with a focus on clinical trial design; and (3) collaborate with WFBCCC investigators from all
research programs to provide expertise in qualitative research and patient-reported outcomes for grant
development; abstracts, presentations, and publications; research using registry data; and clinical trial design.
Over the current project period, Q-PROSR has been a highly utilized shared resource, providing services to 82
investigators, of whom 30 are WFBCCC members who consumed the vast majority (72.5%) of service hours. Q-
PROSR services were included in 40 cancer-relevant grant applications, of which 7 were awarded (6 NCI and 1
NCCIH). Additionally, Q-PROSR provided services for investigators on 12 ongoing cancer-relevant grants that
expanded their scope to include Q-PROSR. In the short period since Q-PROSR’s establishment, it has already
been instrumental to 5 cancer-relevant publications and 8 cancer-relevant manuscripts under review. With the
formative nature of Q-PROSR’s research and the typical lag time fromformative research to publication, a steady
increase in Q-PROSR publications is anticipated. In addition to publications, Q-PROSR’s scientific impact is
evident through collaboration on formative research to refine cancer-relevant interventions evaluated in 2
randomized controlled trials; generationof preliminary data for grant proposals; and collaborations with the Office
of Cancer Health Equity (the supporting unit of the WFBCCC Community Outreach and Engagement efforts) to
prioritize and shape research initiatives aimed at reducing disparities in the WFBCCC catchment area.